Computational and theoretical understanding of regulatory mechanisms shaping natural vision

Project Summary/Abstract
How is our visual system capable of making sense out of the complex pattern of light received in the retina?
Machine vision has recently been successful at solving complex tasks on natural images such as object
classification. Thus, we can use these models to infer computations which transform the pattern of light intensities
driven by a natural image all the way up to the behavioral output such as the category of objects in the image.
However, the models of vision offered by machine vision don’t provide insight into the cellular and molecular
mechanisms in the visual system. On the other hand, classical models of visual system offer biologically faithful
accounts for multiple phases the visual system goes through during development, from before eye-opening to
adulthood. However, their scope is often very limited and they cannot provide functional accounts for the cellular
and molecular mechanism they model.
In this proposal, my aim is to put large-scale models of object recognition under biological constraints to be able
to understand the computational and functional roles of those constraints. To this end, I focus on a theoretically-
tractable aspect of optimization problems that both natural vision and machine vision face: regularization.
Regularization refers to the parts of optimization goal that subject the mapping between input and output to some
constraints usually related to resources e.g., energy efficiency in biological systems or robustness to input noise
in machine vision.
I hypothesize that regulatory mechanisms in natural vision have a fundamental computational role in shaping
the visual cortex rather than the mere maintenance and stability roles they are often attributed to. To test this
hypothesis, I aim to conduct a series of computational, theoretical and eventually experimental steps (in
collaboration with experimental labs). In Aim 1, I build large-scale models of the visual cortex and I train them
under different regularization terms, notably cellular-level regularization constraints mimicking neuronal self-
regulatory processes. I then assess those models under a battery of functional and brain similarity measures. In
Aim 2, I build a theoretical framework to gain a fundamental understanding of how these regulatory mechanisms
relate to each other. Finally, in Aim 3, I develop experimental protocols to validate the predictions made by Aim
1 and Aim 2. Based on my preliminary results, I hypothesize that retinal spontaneous activity can play a
significant regulatory role with functional implications for natural vision and I envision a new use for retinal
prosthetic devices as valuable experimental tools to study visual development.

Public health relevance
Narrative Disruption of normal development of the visual system leaves lifelong perceptual and cognitive impairments. Understanding the role of cellular and molecular mechanisms responsible for the normal development of vision requires a deep insight into the complex computational tasks our visual system is solving. I aim to achieve such deep insight through 1) making models for solving the task under biological constraints and 2) understanding the theory of tasks under those constraints and 3) proposing novel experiments to validate and solidify the insights from modeling and theory.